Molecular and Cellular Alcohol Research Training

The Bowles Center for Alcohol Studies (BCAS) “Molecular and Cellular Alcohol Research Training” program at
the University of North Carolina at Chapel Hill is designed to promote the development of promising
postdoctoral research fellows as independent investigators and scientific leaders who will investigate the
pathogenesis of binge drinking and alcohol use disorder using modern molecular, genetic, biochemical and
imaging techniques. Training of the postdoctoral fellows will be individualized with the most important
component being the research conducted by the trainee in the faculty mentor's laboratory. In addition to hands-
on alcohol research, training will include seminars and conferences, activities on responsible conduct of
research and rigor/reproducibility, professional development, didactic courses, supporting diversity in the
scientific workplace, and other training as needed to prepare fellows for independent research. The training
faculty will consist of 18 funded investigators from multiple departments at the University of North Carolina at
Chapel Hill. These faculty have a documented history of close interaction and collaboration. The trainees will
benefit from the unique strengths of alcohol research at the University of North Carolina BCAS, which include
the NIAAA-funded P60 Alcohol Research Center with its scientific research core and shared facilities, the UNC
Neuroscience Center, and the North Carolina Translational and Clinical Sciences Institute (NIH-funded Clinical
and Translational Science Award). The training program will be led by Co-Directors, Drs. Donita Robinson,
Fulton Crews, and Thomas Kash, with the assistance of two senior alcohol researchers, Drs. Clyde Hodge and
Joyce Besheer, who will constitute the Training Program Advisory Committee. The External Advisory
Committee provides another level of oversight. The program proposes seven post-doctoral fellow slots per
year. Trainees will typically receive two years of research training with the possibility of a third year and with
external support sought for later years. This institutional training grant has a strong track record and will
promote intensive training in molecular, biochemical and imaging techniques and basic pathophysiology in a
stimulating environment, leading to broadly trained independent investigators capable of adapting to the rapid
methodological and conceptual advances in research.

Public health relevance
The goal of this grant is to train alcohol research scientists. Training scientists in alcohol research methods is essential to understanding the complex nature of binge drinking and alcohol use disorder. Multi-disciplinary training in molecular mechanisms of alcoholic pathology will cover fetal, brain, genetic, behavioral and other pathologies involved in long-term drinking.